NCHS-CDC-NHANES (For Audiometric Exams and Hearing-Related Questions in NHANES)

To provide support to the National Center for Health Statistics (NCHS), CDC for audiometry testing and related questions on hearing loss and noise exposure in children aged 6 to 19 years and older adults aged70 and older in the National Health and Nutrition Examination Survey (NHANES) for data collection years 2017–2018. The study collects pure-tone, air conduction hearing thresholds at .5, 1, 2, 3, 4, 6, and 8 kHz in each ear separately, as well as otoscopic exams, tympanometry, and acoustic reflexes on representative samples of the non-institutionalized U.S. population in sound-treated booths meeting recommended ANSI standards. Questionnaire information about tinnitus (frequency and degree of burden), use of hearing aids and other assistive devices, as well as exposure to firearms or other sources of loud noise are collected in home interviews prior to the subjects’ visit to the mobile exam centers (MECs) for audiometric exams. A similar hearing component was part of earlier NHANES III, 1988–1994, and NHANES 2005–2010 conducted on a representative samples of U.S. children and older adults. One of the Healthy People 2010 goals is to assess (with the goal of reducing) noise-induced hearing loss in adults. For this purpose, audiograms are examined and “notches” identified in the higher frequency ranges at 3, 4, or 6 kHz as a surrogate marker of noise exposure. Computer algorithms to identify the notches have been developed. Prior NHANES data serve as a baseline, but to assess progress on this goal in Healthy People 2020, hearing thresholds of U.S. children/adolescents must be measured again in NHANES. NCHS directs the data collection contractor (i.e., WESTAT) in establishing and revising protocols for the hearing component and in preparing training and field manuals. NCHS provides NIDCD with an opportunity to collaboratively review summary data for purposes of quality control during the data collection period and, also, provides NIDCD with a data file for quality review approximately three months before the Public Use data release.